The ubiquitin ligase Itch limits mTORC1 nutrient sensing in B cells

PROJECT SUMMARY/ABSTRACT
Severe immune dysregulation occurs in rare patients with loss-of-function mutations in the gene encoding the
ubiquitin ligase Itch. 14 patients have been identified, presenting with chronic lung disease, various forms of
organ-specific autoimmune diseases, and high levels of autoantibodies. One patient was successfully treated
with a bone marrow transplant, showing that disease is caused by malfunctioning immune cells. Murine studies
have enabled mechanistic dissection of Itch function in T cells, but these roles do not adequately explain why
patients develop autoimmunity, particularly autoantibodies. Recent evidence shows that Itch directly restrains B
cells to limit antibody production. In activated B cells, Itch prevents aberrantly high levels of the master metabolic
regulator, mechanistic Target of Rapamycin Complex 1 (mTORC1) activity, a hallmark of lymphocytes in patients
with more common autoimmune diseases such as lupus. Despite the evidence that Itch functions within B cells
to restrain mTORC1 activity and antibody responses, where Itch functions within the mTORC1 activation
pathway is unknown. These mechanisms are germane to understanding formation of autoimmunity in Itch
deficient patients. The objective of this proposal is to determine how Itch limits aberrant mTORC1 activity in B
cells. Our central hypothesis is that Itch regulates mTORC1 nutrient sensing to limit mitochondrial activity. Using
primary mouse B cells and patient-derived lympoblastoid cell lines that are Itch-deficient or Itch-sufficient, we will
1) define the nutrient-sensing mTORC1 activation pathways regulated by Itch in B cells, and 2) determine how
Itch inhibits purine nucleotide-mediated mTORC1 activity. This work will determine if Itch exerts regulatory
control over mTORC1, providing a new target for the design of therapies that can treat rare patients with Itch
mutations and those with mTORC1-associated autoimmune diseases.

Public health relevance
PROJECT NARRATIVE Rare patients lacking Itch develop severe multisystemic autoimmune diseases and high levels of autoantibodies. Prior research does not explain the formation of humoral autoimmunity as a consequence of Itch deficiency. This research will determine how Itch dampens metabolic signaling in B cells, which will advance efforts to reduce autoantibody levels and ameliorate autoimmune diseases in patients with Itch mutations.